Quantifying body shape in pediatric clinical research

Project Summary/Abstract. Excess adiposity is associated with metabolic changes that significantly increase
the risk of developing 13 types of cancer. It is estimated that up to 20% of cancer cases are caused by obesity
and that obesity prevention can play a significant role in the reduction of cancer incidence. Among obese
adolescents, the most rapid weight gain has been shown to occur between 2 and 6 years of age. Despite clear
connections between these factors and obesity risk, the study of obesity in early childhood is limited by the lack
of body composition technologies appropriate for this age range. The long term goal of the Shape Up! Keiki is 1)
to provide pediatric phenotype descriptors of health derived from detailed body shape scans from high-speed
and high depth resolution 3D cameras, and 2) to provide the tools to visualize and quantify body shape in
research and clinical practice. Our approach addresses technology issues that have hindered body composition
research in this age range including participants' inability to hold still, follow directions, small body size, and rapid
fluid shifts. To develop our body composition models, we will recruit 360 ethnically-diverse children from birth to
5 years stratified by sex and BMI-Z. Our central hypothesis is that optical estimates of body composition suitably
represent a 5-compartment (5C) body composition model for studies of adiposity and health in young children
and are superior to that of simple anthropometry and demographics. Our specific aims and subaims are as
follows: 1) identify the statistical shape descriptors from 3DO scans that best represent 5-compartment body
composition in an ethnically-diverse pediatric population, 1(a) identify the relationships that best link 3DO shape
descriptors of body subregions (arms, legs, trunk), and matching volumes and body composition measures, 1(b)
calibrate automated 3DO anthropometry to clinically relevant girths and lengths, Exploratory) identify accessible
combinations of 3DO and TBW that can be calibrated to criterion 5C measures of fat and hydration, 2) identify
the factors that define the precision of accessible 3D optical body composition estimates to monitor change in
body composition and metabolic health interventions, 3) contrast the association of body shape, 3DO, and 5C
criterion body composition to pediatric health indicators including clinically relevant exposures (SES, nursing
duration, birth method, nutrition) and development. The rationale for this study is that early life access to accurate
body composition data will enable identification of factors that increase obesity, metabolic disease, and cancer
risk, and provide a means to target interventions to those that would benefit. The expected outcome is that our
findings would be immediately applicable to accessible gaming and imaging sensors found on modern
computers.

Public health relevance
Project Narrative. The proposed research is relevant to public health because they have the potential to provide a better understanding of which young children are at high risk of metabolic consequences of obesity. Thus, the advances proposed are expected to have a high impact to the health and wellbeing of all US citizens because metabolic diseases, such as obesity and its complications, are currently the number one killers of adults, and are becoming epidemic in children as well. This is relevant to the part of NIH's mission which focuses on the prevention of disease by supporting research in the diagnosis of human diseases.